Contribution of adipocyte inflammation to parturition timing

PROJECT SUMMARY
Abnormal timing of labor, especially preterm birth (PTB), is a major threat to maternal and infant
health. Mothers with pre-pregnancy obesity have increased risk for pregnancy complications
including PTB. However, cellular and molecular mechanisms underlying the induction of such
adverse health outcomes in pregnancy remain unknown. Induction of labor is associated with
hormone release (e.g., oxytocin), increase in systemic inflammatory mediators (e.g., fetal DNA,
LPS) and proinflammatory cytokines (e.g., IL-6, TNF), and sympathetic nervous system (SNS)
activation. Here, we aim to define non-dogmatic sources of pro-inflammatory cytokine production
throughout pregnancy that may affect the timing of labor. Specifically, due to its expanded status
in pregnancy and known role in various inflammatory diseases, we propose to study how white
adipose tissue (WAT) inflammation is induced in pregnancy and how such inflammation
contributes to the overall inflammatory balance. Using a mouse pregnancy model, we show that
WAT temporally expands in pregnancy, and that such expansion positively correlates with higher
pro-inflammatory cytokine production by WAT at baseline and uniquely in adipocytes after LPS
sensing. However, whether and how hormonal and inflammatory signals unite to instruct the
timing of labor in WAT remains unknown. Dogmatically, oxytocin is known as the major hormone
responsible for uterine contraction during labor. Recent findings show the ability of oxytocin to
induce lipolysis and change metabolic characteristics of adipocytes via direct SNS stimulation.
We now show that oxytocin and LPS have a synergistic effect on adipocyte IL-6 production, and
that oxytocin-expressing neurons are present in WAT of female mice. Thus, our preliminary data
and published reports support the overarching hypothesis that SNS-derived oxytocin secretion in
pregnancy amplifies WAT inflammation via adipocyte oxytocin receptor signaling. In this proposal,
we aim define how oxytocinergic innervation of WAT affects tissue and cellular inflammation in
pregnancy (Aim 1), and to examine the role of adipocyte oxytocin sensing for amplified
inflammation in pregnancy (Aim 2). Together, these studies will lay novel groundwork for
exploration of peripheral tissue neuro-inflammation in initiation of labor – a timely need given the
increasing prevalence of preterm labor and pre-pregnancy obesity in this country. Further, the
associated training plan will establish a foundation for a successful career as a physician scientist
with a focus on academic obstetrics & gynecology research.

Public health relevance
PROJECT NARRATIVE The risk of pregnancy complications and preterm birth is increased by pre-pregnancy obesity, but the mechanisms behind increased risk are not known. Here, we propose that neuro-inflammatory processes in adipose tissue may shift the balance of inflammation during pregnancy. Specifically, we aim to understand the importance of a new way that oxytocin reaches adipose tissue, and to uncover the molecular processes by which oxytocin shapes adipose tissue inflammatory output in pregnancy.